Matricellular protein CCN3 in vascular homeostasis

SUMMARY
Aortic homeostasis is essential for vascular health. The vascular endothelium is a vital organ whose health is
essential to normal vascular physiology; when dysregulated, it becomes a critical factor in the pathogenesis
of a variety of vascular diseases. Growing evidence indicates that endothelial cells (ECs) play an
underappreciated role in the development and progression of thoracic aortic aneurysm and dissection (TAAD).
Most notably, compromised barrier integrity has been implicated as a precursor to the development of TAA.
Work from our laboratory has led to the appreciation that a member of Cellular Communication Network (CCN)
gene family, CCN3, serves as an important regulator of vascular health. However, the precise physiological
role of CCN3 in vivo as well as the fundamental mechanisms responsible for CCN3’s action remain largely
undefined. Recently, our preliminary studies suggest that CCN3 serves as an endogenous inhibitor of TAAD.
Recently, our preliminary studies suggest that endothelial dysfunction due to CCN3 deficiency predisposes
animals to thoracic aortic aneurysm and dissection (TAAD). In a mouse model of Marfan syndrome
(Fbn1mgR/mgR), global deficiency of CCN3 deficiency exacerbates thoracic aortic aneurysm (TAA) in Marfan
mice characterized by increased aortic root and ascending thoracic aortic dilation, elevated incidence of
vessel dissection, and, as a consequence, enhanced mortality. Similar findings were obtained when
challenging animals with angiotensin II (Ang II). Endothelial restricted knockout mice (EC CCN3-/-)
subjected to Ang II infusion exhibited augmented aortic root and thoracic aortic dilation along with an elevated
severity of aortic wall destruction. Mechanistically, our initial bulk RNAseq studies suggested that loss of
CCN3 perturbs vascular junction and causes aberrant activation of signaling pathways involved in
inflammation. Our subsequent in vivo and in vitro studies further support that key factors secondary to CCN3
deficiency (endothelial barrier disruption, inflammation, reactive oxygen species (ROS)) cause endothelial
dysfunction and play a pivotal role in TAAD development and progression. These observations provide the
foundation for the central hypotheses of this application: CCN3 serves as a critical physiological regulator for
the maintenance of endothelial function essential for the prevention of TAAD. Studies in this proposal will
rigorously address this hypothesis. The role of endothelial CCN3 in mitigating TAAD will be fully characterized.
Mechanistic basis of how CCN3 deficiency leads to endothelial dysfunction will be investigated. The results
of these studies will elucidate the role of CCN3 in controlling endothelial function and the mechanisms
underlying its ability to promote endothelial barrier integrity and limit inflammation.

Public health relevance
The underlying cellular and molecular mechanisms that lead to the development of thoracic aortic aneurysm and dissection (TAAD) remain not fully elucidated. Studies in this proposal aim to characterize the importance of endothelial CCN3 in the maintenance of vascular health and its role against the progression of TAAD. Results gleaned from our studies may facilitate the development of novel therapies to ameliorate TAAD progression.